EIGHTH CONFERENCE ON HEMOGLOBIN SWITCHING

Support is requested for organizing the Eighth Conference on Hemoglobin Switching to take place on May 29 to June 1, 1992. It will represent a gathering of molecular biologists, cell biologists, developmental biologists, and clinical investigators who are directly involved with studies on molecular biology of globin genes and hemopoietic cell differentiation. The duration or the conference will be three days. International participation is anticipated, and support for travel and/or lodging for 15 foreign and 45 USA participants is requested.